Tissue Selective Glucocorticoids

The stress hormone, cortisol, coordinates the body’s chronic metabolism, but also coordinates acute responses to stress by
regulating stem cell differentiation in different tissues, restraining inflammatory and immune responses from being
hyperactive, and coordinates acute metabolic responses to nutrient composition and feeding or fasting. Cortisol is also
known as a glucocorticoid because it controls glucose metabolism. Synthetic glucocorticoids (GCs) are wide used for
reducing pain and inflammation across many diseases, but can cause insulin resistance, muscle atrophy, and osteoporosis.
We have developed an approach to studying GCs that enables us to understand how the glucocorticoid receptor coordinates
these activities by binding to specific genes and changing the proteins made by those genes to control tissue-selective
activity. This occurs as the GCs bind to the receptor and change its shape, enabling it to interact with different enzymes that
control transcription. Previous efforts to understand these processes have been hampered by the fact that most of the existing
GCs that we study are very similar. We instead make GCs that have a full range of desirable and undesirable activities,
which gives us the statistical variance to understand them, a technique we call ligand class analysis, as we identify different
classes of GC ligands that interact with different transcriptional regulatory enzymes to control expression of specific genes.
Another major barrier has been the very wide expertise needed to understand the links between the GC chemical structure,
receptor structure, the interacting coregulators, the regulated genes, and the tissue selective activities. We have assembled
the required expertise and approaches to overcome these barriers by studying GC action on skeletal muscle, stem cell
differentiation into bone, inflammation, and immune responses to colitis. We will use a chemical systems biology approach
with novel GCs along with an integrative structural biology platform to define the signaling code for the glucocorticoid
receptor in these aims: Aim 1 Biology: Identify which GC effects are correlated and which can be separated using
physiologically relevant biology for the study of skeletal muscle, T cell differentiation, inflammation, and colitis, and
osteoblast mineralization and effects on bone. Aim 2 Chemistry: Development of GCs to perturb GR structure and function
in novel ways. We will enlarge three classes of compounds based on specific structural hypotheses to enlarge the chemical-
structural space and test a novel steroidal scaffold to access new chemical space. Chemistry will focus on creating a diversity
of effects on bone versus skeletal muscle while maintaining anti-inflammatory effects of the compounds. Aim 3 Structure:
identify the structural underpinnings of selective GC signaling. We will apply machine learning and regression approaches
to our structural and biological data to build and test models defining the mechanisms drive tissue-selectivity and identify
which processes are globally coordinated to control differentiation and stress responses at an organismal level.
Understanding the structural and molecular mechanisms of selective modulation will lead to breakthrough understandings
of allostery and the development of improved GCs for medicine.

Public health relevance
Glucocorticoids regulate genetic programs in all tissues to control inflammation, metabolism, and differentiation as a primary stress response hormone, but synthetic glucocorticoids can achieve tissue- selective effects through unknown mechanisms. The goal of this project is to understand how differences in the chemical structure of the synthetic glucocorticoids alters the shape of the receptor to differentially control stress responses across tissues, and in doing so develop glucocorticoids for treatment of colitis with improved skeletomuscular on target side-effects